Elucidating mechanisms of PARP inhibitor resistance in IDH-mutant cancers

Isocitrate dehydrogenase (IDH) mutations are found in many malignancies including gliomas,
cholangiocarcinomas, and acute myeloid leukemia. Mutations in the IDH gene lead to the neomorphic production
of 2-hydroxyglurate (2HG), a competitive inhibitor of -ketoglutarate. A series of clinical studies showed
enhanced sensitivity to chemotherapy and radiation therapy, and further characterization by several groups
revealed DNA repair defects in IDH-mutant cancers. Our lab discovered this defect arises from 2HG-mediated
inhibition of the -ketoglutarate dependent dioxygenase KDM4B, which leads to aberrant H3K9 trimethylation at
the site of DNA damage, resulting in chromatin condensation and impairing recruitment of homology-directed
repair proteins to the site of damage. This DNA repair defect yields IDH-mutant cancers sensitive not only to
chemotherapy and radiation therapy, but also to poly (ADP-ribose) polymerase (PARP) inhibitors. This defect is
currently being evaluated in clinical trials using PARP inhibitor monotherapy or in combination with other agents.
Nonetheless, some patients do not respond to treatment, suggesting resistance to PARP inhibitors. Thus, a
critical opportunity to uncover and to describe mechanisms of PARP inhibitor resistance in IDH-mutant cancers
will be addressed here.
Several studies have described mechanisms of PARP inhibitor resistance in patients with mutations in
the breast cancer genes 1/2 (BRCA1/2). These studies have employed the use of PARP inhibitor resistant clonal
lines, as well as a genome scale CRISPR-Cas9 knockout (GeCKO) screen and have identified restoration of
homology directed repair and replication fork stabilization as mechanisms of resistance. This study will employ
similar techniques to study PARP inhibitor resistance in IDH-mutant cancers. Aim 1 will determine mechanisms
of PARP inhibitor resistance in IDH-mutant cancers using clonal cell lines previously established by our group.
RNA sequencing data from these PARP inhibitor resistant clones exhibit differences in transcriptomic profiles,
specifically downregulation of 53BP1, RIF1, and the HP1 isoforms. To deconvolute the RNA sequencing data,
generating constitutive CRISPR-Cas9 knockout cell lines of these genes of interest will allow us to test sensitivity
to PARP inhibition and to evaluate the effects in homology directed repair and chromatin remodeling. Aim 2, on
the other hand, will identify novel genes conferring PARP inhibitor resistance in IDH1-mutant cells using an
unbiased GeCKO screen. Specifically, a publicly available human GeCKO lentiviral pooled library will be
transduced into IDH1-mutant cells, and further challenged with a PARP inhibitor. Two genes involved in DNA
repair and two genes involved in chromatin remodeling will be selected to create constitutive CRISPR-Cas9
knockout cell lines and characterization will be conducted as in Aim 1. Together, this work will reveal undescribed
mechanisms of PARP inhibitor resistance in IDH-mutant cancers, and it will provide insight into combinatorial
therapy with other DNA damaging agents that may synergize to overcome this resistance.

Public health relevance
Targeted therapy agents like inhibitors of poly (ADP-ribose) polymerase (PARP), which target cancers that have DNA repair defects, have been shown to be effective in tumors such as those harboring isocitrate dehydrogenase (IDH) mutations. Nonetheless, drug resistance continues to be a barrier in cancer therapy, mostly in part due to heterogeneity within tumors. This project studies mechanisms of PARP inhibitor resistance in IDH-mutant cancers, laying the foundation to define treatments for IDH-mutant cancers that are effective and personalized.